Purchase of a High-Resolution Ultrasound Imaging System

Project Summary/Abstract: This application describes the proposed addition of an Ultrasound Imaging System to the Loyola University Chicago Cardiovascular Research Institute Small Animal Core Facility. The major benefits of this new state-of-the-art instrument are 4-dimensional imaging, improved spatial/temporal resolution, and streamlined acquisition/analysis workflow. This instrument will deliver an immediate and sustained enhancement of NIH-funded research programs already underway at Loyola University Chicago Stritch School of Medicine. The proposed Ultrasound Imaging System will lay a foundation for future excellence in preclinical studies.

Public health relevance
The application describes the proposed acquisition of a state-of-the-art ultrasound instrument that is useful for imaging of preclinical small animal models such as rats, mice, and rabbits. This device can reveal the 3-dimensional motions of the heart. The system will enhance the ability of NIH-funded investigators at Loyola to conduct scientific research into important diseases, including heart disease and cancer.